Career Enhancement Program (CEP)

Abstract
The purpose of this Career Enhancement Program is to support promising investigators who will participate
in translational breast cancer research projects. There are one to two awardees at any one time, who may be
either MD's or PhD's. Candidates are selected based on their previous accomplishments and their potential and
desire to pursue a career in academic breast cancer research. While our primary focus is to support promising
young investigators at the junior faculty level, it is possible that more established investigators may also be
appropriate for support.
The general outline of each awardee’s research will have been discussed by the applicant and the Selection
Committee as a part of the selection process, and a principal mentor from the Program Faculty will be agreed
upon. Awardees will receive further guidance from the Executive Committee and the selected mentor in
developing their translational research projects throughout the award period. They will also participate in an
extensive set of seminars, professional development courses, and clinical opportunities.
The research environment at the Baylor Breast Center is ideal for supporting translational activities. Scientific
excellence in breast cancer research continues to be reaffirmed by the award of both individual and collaborative
grants, while both national and local programs of clinical investigation are well established at the Baylor Breast
Center and can serve to assist in the translation of research findings into clinical practice. This is an excellent
setting for enhancing and focusing the careers of outstanding investigators on productive translational research
in breast cancer. Indeed, of the 21 young investigators who received partial support from this program in the 26
years since our first SPORE award, most are active in academic research positions in breast cancer, and four
have important roles in this new SPORE proposal including one project leader.

Public health relevance
Narrative The central goal of our translational research is to get the most up to date laboratory research and the most current clinical experience to talk productively to each other, for the most rapid and efficient progress toward controlling and eliminating breast cancer. Thus we have designed this career enhancement program to expose young researchers to the full range of the breast cancer research experience in a vigorously translational environment, whatever their initial training was, as they move towards research independence.